Cancer Prevention and Control Program

PROJECT SUMMARY/ABSTRACT – CANCER PREVENTION AND CONTROL PROGRAM
The Cancer Center Cancer Prevention and Control Program, led by Clapper and Hall, is comprised of 39
Members. The Program’s total peer-reviewed funding is $7.3M (direct costs), of which $2.9M is from the NCI.
CPC members have been highly productive, generating 859 publications with strong evidence of intra-
programmatic (18%) and inter-programmatic (26%) collaboration. Members were awarded several team-
based grants since the last review, including 2 U54s, a UG3, and a grant from Pfizer’s Institute for
Translational Equitable Medicine, and a T32 training grant for postdoctoral fellows.
The mission of CPC is to reduce the morbidity and mortality associated with cancer by identifying biological
and behavioral processes underlying cancer risk, prevention, and control. The overarching goals of the
Program are to: 1) Assess the basis of cancer risk at multiple levels (genetic, biological, environmental, and
behavioral) and identify biomarkers for early detection; 2) Improve cancer and genetic risk communication to
support complex decision-making and enhance outcomes in at-risk populations and survivors; and 3) Modify
cancer risk through enhanced surveillance, preventive intervention and therapeutic interception in high risk
and underserved populations to improve cancer outcomes. Within each theme and across the Program is a
strong focus on health disparities, community outreach and engagement, and diversity, equity and inclusion.
Studies uniquely span the continuum of cancer research, including preclinical experimentation, clinical and
community-based interventions, and survivorship. Multidisciplinary teams, with expertise in molecular biology,
oncology, psychology, medicine, epidemiology, public health, and biostatistics, conduct innovative research to
reduce cancer risk, enhance psychosocial and decisional support, and improve outcomes using novel
interventional and surveillance strategies. These efforts result in a productive research environment that fosters
multidisciplinary collaboration and the successful development and implementation of new state-of-the-art
approaches for reducing cancer risk and enhancing outcomes among high-risk populations, cancer patients, and
their family members. Efforts to address cancer health disparities in the catchment area and ensure equity and
inclusion among diverse populations, in close partnership with the COE and community stakeholders, permeate
the Program and remain a priority. CPC faculty actively participate in Cancer Research and Training educational
activities, and serve as mentors for postdoctoral trainees, physician scientists and under-represented
undergraduate interns. CPC members have successfully accrued 12,860 research participants to interventional
and non-interventional studies during the past 5 years (2019-2023), 49% of whom are minority subjects, and
utilized all 11 CCSG-supported Shared Resources.